DSHB: Innovations in open sharing of antibodies for research

Project Summary/Abstract
The Developmental Studies Hybridoma Bank (DSHB) has existed since 1986 as a resource to facilitate
the sharing of open-source monoclonal antibodies for research. The central mission of DSHB is four-
fold: 1) to maintain and distribute monoclonal antibodies (mAbs) and hybridomas shared by the
inventing scientists, 2) to provide this service at cost and without regard for commercial popularity,
ensuring the availability of rarely used antibodies in smaller fields of research, 3) to provide accurate
characterization and validation information on the antibodies and outstanding customer support, and 4)
to pursue innovative methods for developing, using, and sharing mAbs. DSHB is an academic unit and
has been self-supported by user fees since 1997. Whereas the savings afforded researchers and
funding agencies have been substantial, the DSHB's at-cost pricing model has limited funds available
for developing new ideas and practices to improve the open-source distribution of mAbs. The recent
availability of mAbs from non-rodent hosts (e.g., rabbits), a dramatic increase in the overall number of
mAbs (including recombinant antibodies) coupled with the awareness that many are poorly validated,
and a flood of information on the use and limitations of these innumerable reagents has opened several
opportunities for DSHB to expand and extend our services to these high-priority areas. The aims of this
proposal are (1) to better develop new open-source non-rodent hybridoma methodology, (2) to perform
antibody validation for large, less well-characterized collections of mAbs to improve model organism
research, and (3) to further develop DSHB web-based informatics and expand purified antibody product
offerings. We expect these proposed studies will enhance the rigor, reproducibility, and translatability of
model animal research by developing technologies, tools, and resources that will enable more effective
use of mAbs in animal models across a broad range of research areas.

Public health relevance
Project Narrative Monoclonal antibodies are essential reagents for basic research in animal model organisms and human cells, enabling numerous discoveries that have been translated into human public health benefits. The findings of these proposed studies are relevant to, and will benefit public health by continuing to supply high-quality, open-source, and validated monoclonal antibody resources at reasonable cost for enhancing the rigor, reproducibility, and translatability of biomedical research, especially those using animal models.